Neurobiological responses of somatostatin neuronal circuits to environmental light disruptions during pubertal development

Over 80% of the world's population lives under light-polluted skies, with indoor light exposure rising due to factors
like electronic devices. Exposure to altered light environments induces circadian disruptions, leading to adverse
neurophysiological and behavioral changes including anxiety disorders. Adolescents, who often have altered
sleep patterns and extensive electronic device use, are particularly vulnerable to circadian disruptions. However,
the neurobiological effects of light interventions on brain circuits and behaviors during pubertal development are
understudied. Mammalian light perception involves specialized retinal cells that communicate light information
to various brain regions, including the medial amygdala (MeA), which processes environmental cues to control
emotional responses. Our long-term goal is to understand how the MeA circuit adapts to light
environments during adolescence, and whether light interventions can enhance resilience and prevent
anxiety disorders induced by circadian disruptions. We recently demonstrated that altered light
environments during adolescence increased avoidance behaviors, increased somatostatin neuronal activity and
decreased inward-rectifying potassium channels expression in the MeA. MeA neurons in turn project to the bed
nucleus of the stria terminalis (BNST), a brain region involved in avoidance responses. Given the key role of
somatostatin signaling in the amygdala in regulating affective behaviors, we seek to characterize the
mechanism by which somatostatin neurons in the MeA adapt to light environments to regulate emotional
responses and promote resilience. We will test the general hypothesis that somatostatin neurons in the MeA
act as a key regulator, capable of adjusting to light environments to influence adaptive responses (resilience).
Three Specific Aims are proposed to functionally dissect the role of somatostatin neurons in mediating lightinduced adaptive behaviors: In Aim 1, we will investigate whether somatostatin neurons in the MeA are required
for light-induced avoidance behavior through chemogenetic manipulations and cell-type-specific ablation of
somatostatin expression in adolescent mice exposed to chronic light cycles disruption. In Aim 2, we will establish
the role of inward-rectifying potassium channel in regulating light-induced increase of somatostatin neuronal
activity in the MeA regulating avoidance behaviors. In Aim 3, we will study MeA somatostatin cells downstream
projections to uncover the circuits mediating light-induced avoidance behaviors by employing in vivo fiber
photometry for neuronal activity and somatostatin release recording in the BNST of adolescent mice exposed to
chronic light cycle disruption. We will also use optogenetic approach to inhibit MeA somatostatin synapsis
terminals into the BNST while testing adolescent mice for light-induced avoidance behaviors. By integrating a
diverse set of cutting-edge methodologies, this project will advance our understanding of the adaptive
mechanisms of the MeA somatostatin circuit in response to light environments. Our goal is to provide
pre-clinical data to develop safe light interventions that enhance resilience and prevent affective
disorders in adolescents experiencing circadian disruptions.

Public health relevance
Most of the global population today experiences light pollution and altered light environments which have been linked to adverse neurophysiological and behavioral effects. Despite adolescents being extensively exposed to chronic light cycles disruption due to electronic device use and changing sleep patterns, there is a lack of studies examining the neurobiological impacts of chronic light disruptions on brain circuits during pubertal development. The project aims to investigate the mechanism by which medial amygdala somatostatin circuit adapts to chronic light cycles disruption in adolescent mice, shedding light on the potentially deleterious effects of altered light environments on brain circuits regulating affective behaviors during adolescence.